Interplay between circadian and reward pathways in homeostatic response and pathology

Project Summary: Parent award: Biological processes ranging from gene transcription to behavior oscillate and
are synchronized to the 24-hour day/night cycle. Mammalian circadian rhythms, orchestrated by the
hypothalamic suprachiasmatic nucleus (SCN) allow appropriately timed physiological and behavioral responses
to daily recurring external cues (i.e. sunrise or timed meal availability). The resulting synchrony of physiology to
the astronomical day maximizes metabolic efficiency and good health. However, many of the stresses of modern
society (i.e. artificial lighting and omnipresence of food) weaken and desynchronize circadian rhythms. This in
turn increases the prevalence of many pathologies including metabolic disorders and neurodegenerative
diseases. The aim of my laboratory is to determine how circadian rhythms are synchronized to external cues
(circadian entrainment) and how desynchronization impacts health. Although the neuronal pathways of light-
driven entrainment are well-established, how other external cues, such as food availability, social interactions or
exercise, influence the workings of the SCN remains unknown. In a recent breakthrough, we identified a neuronal
connection between midbrain dopaminergic neurons that are activated in response to salient events and SCN
neurons that express the dopamine receptor Drd1. We showed that this pathway accelerates photoentrainment
and drives palatable food consumption outside of mealtimes. In parallel, we identified a novel molecular player
that is necessary for anticipation-related activity to time-restricted food access. Here, we propose to leverage
our expertise in disentangling circadian entrainment neurocircuitry to delineate the mechanisms by which
rewarding cues modulate the SCN circadian clock. Furthermore, we will determine whether strengthening
circadian rhythmicity ameliorates symptoms of neurodegenerative diseases. Our first objective is to gain a
mechanistic understanding of how salient events impact SCN activity and circadian entrainment. We hypothesize
that activation of dopaminergic signaling decreases the amplitude of SCN oscillation and allows faster
photoentrainment. This novel insight will be useful to develop strategies to curb the negative impact of circadian
desynchrony. Our second goal is to identify the midbrain dopaminergic cell population that targets the SCN and
promotes palatable food consumption outside of meal times, leading to weight gain and metabolic disorder. We
predict that by mimicking dopaminergic signaling in the SCN, we will control food consumption. Delineating this
pathway will provide therapeutic targets against diet induced metabolic dysfunction and obesity. Our final
objective is to determine if high amplitude circadian rhythms, by daily consolidation of light and food access, is
sufficient to slow the progression of a mouse model of Alzheimer’s disease (AD). If successful, entrainment
strategies will become potential treatments for AD patients and people with high-risk of developing AD. We
expect our work will provide a better understanding of the relationship between entrainment cues, physiology
and behavior while providing tangible strategies against the adverse consequences of circadian misalignment.

Public health relevance
Public Health Statement: Obesity and Alzheimer’s disease (AD) devastate millions of Americans and place a tremendous burden on our healthcare system. Necessities of modern society put immense pressure on human physiology by forcing incongruity between endogenous circadian rhythms and environmental cycles, which worsens a range of health issues including obesity associated maladies and AD. This project aims to identify the neuronal circuits and the molecular players that control circadian rhythms and therefore identify therapeutic targets to circumvent these pathologies.